Systems-level mechanisms of small cell lung cancer dynamics

PROJECT SUMMARY
Small cell lung cancer (SCLC) is lung cancer of neuroendocrine origin, characterized by aggressive growth and
rapid spread. Initially responsive to treatment, SCLC nearly invariably relapses and leads to patient death
within 2 years. Recent work has shown that SCLC is a highly heterogeneous disease comprising multiple
cellular subtypes within a tumor that exhibit differential sensitivity to drug treatments. However, SCLC research
to date has focused on two major areas, which have not yet been unified. Cell-molecular studies have revealed
two broad phenotypic subtypes within a tumor population, neuroendocrine (NE) and non-neuroendocrine (non-
NE). Receptor-ligand interactions such as those between Notch receptor and its ligand DLL4 have been found
to play a role in inducing transformations between these different cell types, such as the transition from NE
cells into a non-NE phenotype. Single-cell RNA sequencing approaches have produced transcriptional data
showing regulatory pathways active in SCLC tumor cells, which drive cells towards broadly NE or non-NE cell
processes. While both cell-signaling approaches and transcriptional approaches have provided valuable
insights into SCLC phenotypic subtype differentiation, it is not clear how transcriptional regulation of subtypes
is linked to cell population behaviors that enable tumor growth. A systems-level picture of SCLC tumor
behavior is not achievable without understanding how intercellular dynamics and cell-cell signaling in the tumor
directly affects transcriptional activation, and how transcriptional activation leading to subtype transitions
affects these intercellular dynamics. I present an approach to study both of these mechanisms of phenotypic
subtype differentiation in SCLC, using computational modeling of population dynamics to characterize cell-cell
interactions and tumor makeup with regard to phenotypic subtypes, and Boolean logic modeling to
characterize transcriptional signaling pathways intracellularly to provide detail about how different transcription
factors can result in differentiation into each phenotypic subtype. I will also study both of these processes
experimentally, investigating means by which to destabilize each subtype and lead to inhibition of tumor
growth, while using results to further refine my mathematical models. Studying each area in the context of the
other is expected to improve knowledge of tumor behavior. Enhanced characterization of tumor subtype
sensitivities with regard to growth or phenotypic transition will lead to new therapeutic strategies for SCLC
patients, which will be extremely significant in improving patient outcomes. This project will result in a systems-
level understanding of the correspondence between transcriptional networks and tumor subtype composition in
SCLC, bringing to light targeted treatment options to destabilize the system.

Public health relevance
PROJECT NARRATIVE Small-cell lung cancer (SCLC) has a dismal prognosis, with only up to 1-year survival rate for treated disease, and is responsible for approximately 30,000 deaths in the United States each year. SCLC is particularly capable of developing treatment resistance due to extensive phenotypic heterogeneity leading to multiple cellular subtypes within a tumor, where responses to perturbations such as treatment lead to tumor cell differentiation into less sensitive and more resistant subtypes. I will study SCLC phenotypic heterogeneity, and specifically subtype characteristics, at both the cellular (tumor cell population) level and molecular (transcriptional signaling pathways) level, leading to increased insights into the determinants of each phenotypic subtype and subsequently the optimal protein targets for treatment.